Alternating Current Electrolysis for Organic Synthesis

PROJECT SUMMARY
With growing concerns regarding the environment and sustainability, there is an increasing
demand for integrating green chemistry and green engineering into the pharmaceutical industry.
Electrochemical organic synthesis represents a green and advantageous alternative to traditional
synthetic methods because it directly uses electrons from a power source to complete the redox
transformations, which can cut down on the usage of chemicals, reduce waste, and offer
improvements in cost, safety, and sustainability. However, the current reaction library of
electrosynthetic methods is limited. Therefore, there is a critical need for new electrolytic methods
that offer new chemical reactivities.
The proposal is focused on studying the mostly unexplored alternating current electrolysis for
organic synthesis. Unlike the conventional electroorganic synthetic methods using a constant
voltage or current, alternating current electrolysis uses an alternating voltage to drive the redox
transformations of substrates. Alternating current electrolysis offers a unique reaction
environment where two redox-opposite reactions can occur spatially and temporally close to each
other and can be easily adjustable by merely controlling the alternating current voltage supply.
The overall goal of this proposal is to exploit this unique reaction environment of alternating
current electrolysis to achieve new reactivities that are not currently accessible by the existing
synthetic methodologies, serving as a critical step towards the long-term vision of the electrically
driven green synthesis of drugs.

Public health relevance
PROJECT NARRATIVE With growing concerns regarding the environment and sustainability in the pharmaceutical industry, synthesis of drugs using electricity is emerging as a green and advantageous alternative to traditional synthetic methods because it can cut down on the usage of chemicals, reduce waste, and offer improvements in cost, safety, and sustainability in pharmaceutical production. The first step towards the long-term vision of electrically-driven green synthesis of drugs is to build up an electrosynthetic reaction library. The goal of this proposal is to establish alternating current electrolysis, which uses alternating current to drive chemical reactions, for new reactivities in organic synthesis.